Tuning peptide specifities for T cell tolerance in Type 1 diabetes

Project Summary/Abstract
Type 1 Diabetes (T1D) is a classical T-cell mediated autoimmune disease and substantial data implicates
insulin as a dominant autoantigen in T1D disease. In the NOD mouse model of T1D, notable studies have shown
that mice lacking native insulin expression, but with an altered insulin sequence to maintain blood glucose levels,
are completely protected from insulitis and diabetes. Growing evidence also indicates that insulin peptide binding
and orientation within MHC Class II (peptide register) is important in determining the strength of interaction and
recognition by autoreactive T cells. In collaboration with the Kappler lab, we have uncovered an unusual peptide
binding characteristic of the dominant insulin epitope InsB:9-23. The majority of InsB:9-23-specific CD4+ T cells
in the periphery recognize insulin bound in this unusual register 3, and by knocking in a single amino acid
variation (R to E) into just one copy of the insulin gene in NOD mice (Ins2EE/+), the mice are completely protected
against diabetes.
The development of a “super agonist” version of the insulin dominant epitopes allows us to address several
key questions surrounding the biochemical pathways of peptide generation, presentation by MHC molecules,
and recognitions by auto-reactive pathogenic T cells. Do mutations of the major epitope in the insulin gene allow
CD4+ T effectors or Treg cells specific for these alternative epitopes to develop? Are mimotopes of these
pathogenic epitopes capable of dramatically altering disease outcomes? Are we able to fine tune these epitopes
to alter tolerance mechanisms to shift from deletion to Treg induction? Recent work in our lab has focused on
the identification of the insulin-specific repertoire on key mouse backgrounds, and we plan to utilize these tools
and well-characterized mouse models to examine the effects of altering insulin expression, thymically and
extrathymically. These tools as well as our experience with the generation of numerous TCR-transgenic mouse
lines will allow us to address these questions in the context of T1D.
Thus, we hypothesize that alterations to epitope presentation and TCR affinity drive the tunning of
the TCR repertoire towards tolerance and away from self-reactivity. Using Insulin as a model antigen, we
propose to test our hypothesis through the following specific aims:
Aim 1: Define the role of central tolerance upon the deletion of insulin-reactive clones
Aim 2: Characterize the effects of peripheral tolerance on insulin-reactive T cells
Aim 3: Explore mechanisms of dominate tolerance to understand the potential for translation into
therapeutic treatments for T1D
Through these experiments, we hope to gain a nuanced understanding of how changes in insulin epitopes and
antigenicity drive the pathogenesis of diabetes and identify targets for future immune modulation and
therapeutic intervention for T1D treatment and prevention.

Public health relevance
Project Narrative This project aims to understand how alterations in insulin peptide presentation can promote changes in T cell selection that lead to increased autoimmunity and diabetes pathogenesis. Improved knowledge of how changes in peptide epitopes affect the generation of pathogenic effector T cells versus selection of suppressive T regulatory cells will have broader application to a more mechanistic understanding of T cell selection in the thymus as well as for mechansisms of peripheral tolerance. Finally, results of our work will determine if manipulation of insulin peptide epitopes can provide a potential target for furture efforts in tolerance induction and therapeutic intervention Type 1 diabetes.